Stereoselective Synthesis of Biologically Relevant Heterocycles via Brønsted Acid Catalysis

PROJECT SUMMARY The goal of this proposal is to generate innovative strategies for the asymmetric preparation of different heterocyclic motifs, including N-containing compounds, that contain a chiral center. Realization of this goal is expected to benefit medicinal chemistry campaigns because >59% of FDA approved drugs include a nitrogen- containing ring system and >56% of FDA approved drugs contain a stereogenic center, the absolute configuration of which is often critical to the activity of the molecule. To induce asymmetry in the proposed processes, a Brønsted acid will be used to catalyze a stereoselective cyclization reaction, with a focus on the use of commercially available chiral phosphoric acids. We hypothesize that the chiral phosphoric acid will complex with the starting hydroxy and amino esters and nitriles to initiate a cyclization reaction that preferentially generates one product enantiomer over the other. Our methods rapidly build complex molecules under mild conditions, and our research will result in a significant advance over current state of the art. Preliminary results support the validity of our approach and we will offer insight into the potential uses of the generated products. The ring structures we will prepare are ideal candidates for further manipulation into other biologically relevant structures or for diversification and evaluation themselves. Notably, these investigations will be advanced primarily by M.S. and undergraduate student researchers.

Public health relevance
PROJECT NARRATIVE In nature many biologically active molecules have a specific 3-dimensional shape associated with them and often this shape possesses a certain handedness, or chirality, which is critical for its activity. This proposal aims to develop new methodologies for the preparation of cyclic molecules with a specific geometry that belong to classes of compounds with known biologic activity. Support will increase the capacity of the PI and institution to support undergraduate students, particularly those from underrepresented groups, and the added diversity is expected to lead to important new approaches.